The Jail-to-Homelessness Pipeline and Serious Mental Illness

PROJECT SUMMARY / ABSTRACT
This career development proposal will support Dr. Enrico Castillo to become an independent researcher
focused on serious mental illness (SMI), incarceration, homelessness, and public mental health systems, with
expertise in conducting mixed methods studies to improve the capacity of public systems to eradicate the
health and social inequities experienced by individuals with SMI. People with SMI experience severe
inequities, which are particularly evident within homeless populations and correctional facilities where people
with SMI are grossly overrepresented. These national challenges are reflected in Los Angeles County, which
has the largest unsheltered population of people with SMI in the US. The Los Angeles County jail is the largest
facility in the world for the confinement of people with SMI. In the face of scarce public mental health resources
and concentrations of people with mental illness in jails, some have posited that jails may serve important
public health functions and have positive mental health effects on individuals with SMI. This raises important
scientific questions. Dr. Castillo plans to focus his research on understanding the unmet health and social
needs of individuals with SMI by studying the effects of incarceration on subsequent health and social
trajectories—the jail-to-homelessness pipeline. Dr. Castillo’s proposal centers on mentored career
development and research activities that will develop the skills to achieve these career goals: 1) quantitative
analysis of linked administrative data, 2) qualitative research methods, specifically ethnography, archival
research, and mixed methods dialogue, 3) criminal justice systems and vulnerable justice-involved populations,
and 4) dissemination and translation of health services research findings to policy and practice. Given the
challenges of studying individuals after jail release, relatively less is known about the precise relationship
between incarceration and subsequent homelessness and its downstream effects on healthcare and social
trajectories for people with SMI. Fragmented systems of care and siloed data infrastructures are additional
barriers to research, coordination of care, allocation of resources, and public health planning. To address these
lacunae, Dr. Castillo’s research project will 1) use an existing linked administrative database of eight public
service agencies in Los Angeles County to understand whether jail is disruptive to mental health and social
service use and housing stability for people with SMI; 2) conduct archival research and direct ethnographic
observations in the Los Angeles County jail to elucidate the jail experiences and services and ascertain the
mechanisms underlying post-incarceration trajectories; and 3) prepare for a R01 health services research grant
(PAR-17-264). Building on this project’s findings about factors that lead to post-incarceration homelessness,
that future multi-site R01 will employ the same mixed methods to investigate the full circuit of institutional
recidivism (reincarceration, hospitalization, homelessness), to identify the public service use trajectories,
programs, and other mutable factors (individual- to system-level) that prevent or disrupt those outcomes.

Public health relevance
PROJECT NARRATIVE People with serious mental illness are grossly overrepresented in populations experiencing incarceration and homelessness, representing the culmination of health inequities and unmet mental health and social needs. This mixed methods K23 proposal aims to address important gaps in our understanding of the effects of incarceration on homelessness and downstream mental health and social service use by quantitative analysis of an existing linked administrative database, archival research, and direct ethnographic observations of individuals with SMI in jail. The proposed research responds to NIMH Strategic Priority 4 by strengthening the public health impact of NIMH supported research, particularly Priorities 4.1, 4.2, and 4.4, and the NIMH Division of Services and Intervention Research area of high priority to “Identify new targets for innovative intervention (development/refinement) and service delivery models through research that examines the burdens from mental illness as well as the current use, benefits, safety, costs, and unmet needs for mental health care.”